COMBINED ZDV 3TC VS THE BETTER OF DDI MONOTHERAPY VS ZDV PLUS DDI

This AIDS Clinical Trial Group (ACTG) study compares the efficacy of treatment with 3TC/ZDV in combination versus the better of the two ddI arms in HIV-1 infected children who have received less than 56 days of prior antiretroviral therapy. The study will also evaluate the safety and tolerance of the 3TC/ZDV combination, and correlate quantitative plasma RNA levels with HIV disease progression.